PS23-003 - A Community-based Assessment of Preferences for Long-Acting Antiretroviral Therapy Options Among Cis-gender Black Women across Six Ending the HIV Epidemic Jurisdictions in the South

PROJECT ABSTRACT
Efforts to curb the HIV epidemic in the United States (US) are impeded by suboptimal access and adherence to
antiretroviral therapy (ART), particularly among cis-gender Black women with HIV (CgBWH) in the Southern US
who have lower care linkage, engagement, and viral suppression, and higher mortality, than their male and White
female peers. Long-acting (LA) ART has the potential to transform the HIV treatment landscape, but the uptake
of LA-injectable (LAI) ART has been low due to multi-level challenges and the lack of tailored approaches for
key groups, including CgBWH. To help fill this gap, over the past six years our multidisciplinary team has led
mixed methods research on women’s LA ART interest, preferences, barriers, and facilitators. However, these
data were collected prior to LA ART approval, queried hypothetical use, and did not include young women or
focus on the South. To realize the Ending the HIV Epidemic (EHE) initiative “Treat” pillar, we must develop novel
approaches to optimize and tailor care linkage and ART adherence strategies for CgBWH. This proposal builds
on our existing multisite research infrastructure and robust academic-community partnerships to
explore Southern CgBWH preferences and implementation challenges in the era of approved LA ART; it
will integrate stakeholders’ needs and values to co-create prototype tools for education, referral, and linkage to
HIV treatment tailored to CgBWH. We will leverage the Study for Treatment And Reproductive Outcomes (STAR)
infrastructure, that is currently enrolling 1200 CgBWH in six Southern sites including urban and rural EHE
priority jurisdictions (AL, FL, GA, MS, NC, DC). To advance this work, we will use the Consolidated Framework
for Implementation Research and Human-centered design to inform our data collection, analyses and the
development of educational, referral, and linkage prototype toolkits to support CgBWH LA ART access and use.
In Aim 1 we will examine CgBWH preferences, facilitators, and barriers to LA ART uptake and novel delivery via
an ongoing LA ART survey in STAR (n=1200 CgBWH) and longitudinal interviews with 120 CgBWH who vary
by adherence, LA ART use, age, and rurality. In Aim 2 we will identify strategies to equitably scale up LA ART
for CgBWH through interviews with 60 HIV service providers including from community-based organizations
(CBOs) that vary by role, LA ART availability, funding, and rurality. In Aim 3 we will use human-centered design
approaches via a series of 3 workshops across four CBOs (2 rural, 2 urban) to integrate the voices of CgBWH
and HIV service providers and iteratively develop LA ART educational, referral and linkage tools that are tailored,
acceptable and feasible for CgBWH and a range of delivery sites. Given our established academic-community
research infrastructure, clinical leadership in LA ART programming, and expertise in HIV and women’s health,
qualitative methods and implementation science, we are well-positioned to rapidly implement this mixed methods
study and disseminate knowledge to all stakeholders, thus addressing the EHE “Treat” pillar in HIV hotspots.

Public health relevance
PROJECT NARRATIVE Efforts to curb the HIV epidemic in the United States (US) are impeded by suboptimal access and adherence to antiretroviral therapy (ART), particularly among cis-gender Black women with HIV (CgBWH) in the US South who face intersectional constraints that limit their progression along the HIV care continuum. Long-acting (LA) ART has the potential to transform the landscape of HIV treatment and serve as a tool to help end the epidemic, but to maximize its potential we must develop innovative and tailored approaches to facilitate care linkage and adherence strategies for marginalized populations across rural and urban settings, including CgBWH. In this proposed U01, our multidisciplinary team will leverage existing academic-community partnerships to conduct a mixed methods study that integrates CgBWH LA ART preferences, barriers, and facilitators with qualitative data from HIV service providers on implementation strategies to co-create tailored prototype tools for LA ART education, linkage and referral that will support CgBWH access and uptake across delivery sites.